Indiana University (IU) Clinical Center for Chronic Pancreatitis Clinical Research Network

Chronic pancreatitis (CP) is a progressive disease, often leading to loss of exocrine and endocrine
function and debilitating abdominal pain. It is unknown why some individuals progress and
develop complications, including pancreatogenic diabetes (T3cDM) and/or pancreas cancer
(PDAC). In the Consortium for the study of Chronic Pancreatitis, Diabetes and Pancreatic Cancer
(CPDPC), initially formed in 2015, investigators have proposed and initiated several well-powered
studies of risk factors, environmental influences, and proof-of-concept studies to move the field
forward, particularly those factors that increase the risk of T3cDM and PDAC. In the second cycle
of the CPDPC, this administrative supplement will allow for ongoing recruitment and retention of
subjects in two of the CPDPC’s high-priority longitudinal studies, namely PROCEED and
INSPPIRE 2, as well as DETECT, designed to better define and characterize T3cDM.

Public health relevance
Chronic pancreatitis (CP) is a progressive, unrelenting disease, often leading to loss of exocrine and endocrine function and debilitating abdominal pain, resulting in significant healthcare costs. The Consortium for the study of Chronic Pancreatitis, Diabetes and Pancreatic Cancer (CPDPC), now entering the final year of its second five- year funding cycle, has undertaken comprehensive clinical, epidemiological, and biological characterization of patients with CP (including adults and children with acute recurrent pancreatitis) to develop treatments and gain insight into the pathophysiology of CP and its sequela: chronic pain, pancreatic exocrine and endocrine insufficiency, and the diabetes/pancreatic cancer association. The Indiana University clinical center pledges to continue its contribution to ongoing high-priority CPDPC studies, which are described herein.